RNA as a Hormone: Systemic Signaling in Mammals via Circulating, Cell-Free Small

DESCRIPTION (provided by applicant): This proposal seeks to establish the new scientific paradigm that RNA molecules can function as hormones, traveling via the bloodstream to target organs where they are taken up and influence the activity of specific recipient cells. The conventional paradigm of the endocrine system does not include RNA molecules as a class of hormones. The motivation for trying to establish this paradigm comes from a series of facts: (i) RNA molecules have been shown to function as hormones in plants, (ii) in some animal species (e.g., worms and flies) RNA has been shown to spread throughout the organism and carry information from one site to another, and (iii) we and others have found that at least one class of RNAs, known as microRNAs, are abundantly present in the blood of healthy humans and specific microRNAs accumulate in disease states such as cancer. To establish this new paradigm, we will focus on microRNAs secreted into the blood by cancer cells and use mouse models to determine whether the microRNAs are taken up by and influence distant organs and tissues. In addition, we will purify microRNAs in their natural state from blood and determine whether if re-injected into the bloodstream they can travel to specific target sites and have a hormone-like action. Establishing this new paradigm would have a major impact not only on basic understanding of human physiology but could also open up new ways of diagnosing and treating disease based on RNA hormones in the blood.

Public health relevance
PROJECT NARRATIVE This proposal is highly relevant to human health because it seeks to identify a new type of hormone molecule that we hypothesize carries signals throughout the human body. Establishing that RNA molecules in the blood can act as hormones could lead to better methods of diagnosing and treating a variety of human diseases. __SpecificAimsTextDelimiter__ This proposal seeks to establish a new scientific paradigm — that RNA molecules serve a hormonal messenger role in mammals, traveling throughout the organism via the bloodstream to be taken up by recipient cells in which they are functionally active. The conventional paradigm of endocrine signaling in mammals encompasses hormones derived from a variety of molecules including proteins, lipids, and steroids but nucleic acids are notably absent from this list. Demonstration of RNA molecules as systemic hormonal mediators in mammals would be a transformative advance. Although such a role for RNA is novel in mammalian biology, there is precedent for systemic signaling by RNA molecules in the plant kingdom. Experiments in cucumber plants have demonstrated that small RNAs, bound to a specific carrier protein, are secreted into the vascular system (i.e., the phloem) and travel to distal tissue sites where they are taken up by specific target cells that are then directly influenced by the RNA cargo. Transport of messenger RNA through the phloem to target specific recipient cells has also been described in pumpkin. Aside from the phenomena in plants, extracellular RNA can be taken up from the environment by a variety of organisms including the nematode C. elegans and a multitude of insect species. Furthermore, systemic spread of RNA-based signals is known to occur in C. elegans, though the mechanism in that case is believed to involve cell-cell transfer rather than the vascular transport mechanism described in plants. Given that RNA has evolved to serve a systemic signaling function in multiple instances in phylogeny, we hypothesize that an analogous hormone-like function exists for RNA molecules in humans and other mammals. In the past, vascular transport of an RNA hormone in mammals may not have been considered seriously because extracellular RNA has been believed to be highly unstable in the circulation due to high levels of ribonuclease activity in blood. We recently refuted this notion by showing that at least one class of RNA (microRNA) is present in the circulation of humans at extremely high levels (up to 10^9 copies per mL per microRNA, with over 100 distinct microRNA species detected) in a highly stable, cell-free form that is resistant to endogenous plasma ribonucleases. Furthermore, we and others have shown that tumors release specific microRNAs that accumulate in the blood where they can serve as biomarkers. Although much interest has been generated in pursuing microRNAs (miRNAs) as blood-based diagnostics for cancer and other diseases, the idea that these circulating molecules could be functioning as hormones has not yet been investigated in a significant way. The high abundance, high stability and accumulation of specific miRNAs in the circulation in disease states such as cancer are all consistent with the notion of a functional, hormonal messenger role for circulating miRNAs. Furthermore, given that the known function of miRNAs in cells is to repress specific messenger RNA targets via base-pairing interactions, miRNA hormones would be well-poised to directly influence gene expression in recipient cells. Demonstrating the concept that circulating, cell-free RNA molecules act as hormones in mammals would establish a new paradigm with broad relevance to human physiology and medicine. Revealing this potentially missing layer of endocrine regulation could be expected to: (i) open up new investigations of RNA hormonal control of a wide range of physiologic and pathologic processes, (ii) create new opportunities for therapeutic interventions via modulation of circulating RNA hormones, (iii) enable new approaches for monitoring human physiology via measurement of RNA hormones in blood, and (iv) lead to a better understanding of important systemic signaling phenomenon that are currently enigmatic (for example, the mechanism of bone marrow suppression observed in the setting of a variety of chronic diseases). Collectively, this new paradigm has the potential to have a wide-ranging impact on human health.